Determining the role of AIRE and AIRE-expressing tumor associated macrophages in tumor growth and immunity

PROJECT SUMMARY/ABSTRACT
AutoImmune Regulator gene (AIRE) prevents autoimmunity by promoting thymic deletion of self-reactive T cells.
While most studied in the thymus, AIRE is also expressed in secondary lymphoid organs, where it is thought to
contribute to peripheral tolerance through interaction with and deletion of self-reactive CD4+ T cells. However,
AIRE’s role in the periphery is likely more multi-faceted than in the thymus. We recently identified AIRE
expression in tumor associated macrophages (TAMs), which are known to inhibit anti-tumor immune responses.
While Aire-expressing tumor associated macrophages (aTAMs) were only recently discovered by our group,
prior work implicates AIRE in inhibiting anti-tumor immunity. Recently available tools to study AIRE in mice have
facilitated investigation of peripheral AIRE expression and aTAMs. We have found aTAMs in several common
solid tumor models expressing common macrophage markers (CD11b, F4/80, and CD64) by both flow cytometry
and mass cytometry (CyTOF). Additionally, interrogation of several public human RNA-seq datasets supports
AIRE expression in tumor resident myeloid cell types. This preliminary data together with the therapeutic
potential for targeting aTAMs to improve cancer immunotherapy make this a population deserving of thorough
functional investigation. This proposal will test the hypothesis that aTAMs are an immunosuppressive,
pro-tumoral cell population. Aim 1 of this proposal will define the phenotypic, transcriptional, and epigenetic
profiles of aTAMs. Aim 2 will determine the mechanism(s) driving induction of AIRE expression in aTAMs. Aim
3 will identify the role of aTAMs in regulating local and systemic immune responses during anti-tumor immunity.
This research approach will be carried out using a variety of methods including single cell analysis via RNA-seq,
CyTOF, flow cytometry, and ATAC-seq, ex vivo co-cultures, and in vivo assays utilizing novel genetic mouse
models. These proposed studies will be the first characterization of AIRE expression in any tumor
resident immune cells and will further establish our understanding of the function of peripheral AIRE-
expressing cell types. This could result in the discovery of novel pathways relevant to therapeutic resistance
and further our understanding of global AIRE function. Translationally, this work may identify novel perturbations
to improve patient responses to immunotherapy. This research project and fellowship training will be
conducted at a top-funded research institution, the University of California, San Francisco (UCSF), in the
laboratories of Dr. Matthew Spitzer, Dr. Lewis Lanier, and Dr. James Gardner with expert mentorship from Dr.
Matthew (Max) Krummel. Dr. Lanier has made extensive foundational discoveries in immune cell biology. Dr.
Spitzer has expertise in systems immunology and single cell methods. Dr. James Gardner has expertise in the
study of peripheral AIRE and mouse model generation. Dr. Max Krummel has expertise in tumor myeloid cell
biology and cancer immunotherapies. Overall, this facility and team provide a rich training environment for
completion of this research and development of professional skills necessary for a career in academic research.

Public health relevance
PROJECT NARRATIVE AIRE is critical for maintaining central and peripheral tolerance to prevent autoimmune diseases but can also play a detrimental role in inhibiting immune responses against cancer. While deletion of thymic AIRE expression has been shown to improve immunotherapy response in certain cancers by allowing the development of autoreactive T cells, whether AIRE expression outside of the thymus is involved in regulating anti-tumor immune responses remains unknown. This proposal investigates the role of peripheral AIRE expression and AIRE-expressing tumor-associated macrophages in tumor progression and immunity with the ultimate goal of improving immunotherapy approaches for cancer treatment.